Predicting and monitoring variations in the effects of vaccines against RSV

Project Summary/Abstract
Respiratory syncytial virus (RSV) causes a large burden of infections in both infants and older adults. Several
alternative strategies for preventing RSV have recently been approved. A variety of products and approaches
are available, including vaccinating mothers to protect infants, administering extended half-life
immunoprophylaxis to infants, and directly immunizing older adults. There is an urgent need to determine the
delivery strategies that will reduce overall disease burden and address disparities in disease burden among
different socioeconomic groups, and to generate timely estimates of effectiveness and safety of these
interventions as they are introduced. This renewal application builds on the success of our current project
examining spatial heterogeneity in RSV dynamics and the potential impact of RSV vaccines. Disease
dynamics and the impact of vaccines are often characterized at aggregated state or national levels. However,
this aggregation ignores important variability in disease burden between socioeconomic groups. We will use
routinely collected administrative healthcare data from the United States that represent a broad range of
epidemiological settings. We will test specific hypotheses about disparities in disease burden by severity level
and the implications of this variation for vaccine impact and cost-effectiveness. In Aim 1, we will use statistical
models to quantify variability in the burden of RSV infections among outpatients, inpatients, those admitted to
the intensive care unit, and those dying from RSV according to area-based quantiles of socioeconomic status.
Understanding these patterns will help to inform projections of the impact of different prevention strategies. In
Aim 2, we will use transmission models to predict the potential impact of different intervention strategies across
age and socioeconomic groups. In Aim 3, we will use cost-effectiveness analyses to identify the optimal
strategies for infants and for older adults, and we will evaluate the equity implications by quantifying the costs
and benefits of different RSV prevention strategies by socioeconomic group. Finally, in Aim 4, we will extend a
novel analytical framework that will allow for efficient and rigorous evaluations of vaccine effectiveness and
safety, including against rare outcomes, by integrating observational data and trial data. Together the proposed
work will provide critical data on the potential impacts of different RSV prevention strategies and evaluations of
effectiveness that can be used by stakeholders and government advisory committees to inform and update
recommendations for the use of novel RSV vaccines and monoclonal antibodies.

Public health relevance
Public Health Relevance/Narrative Multiple vaccines, as well as extended half-life immunoprophylaxis, are now available to protect infants and older adults from lower respiratory disease caused by RSV, with more options under development. With a number of delivery strategies under consideration, models can play an important role at each stage in the development, testing, and deployment of these new interventions. We will develop and validate a set of statistical and mathematical models that can be used to test hypotheses about the likely impact of alternative vaccination and immunoprophylaxis strategies on disease rates in different populations in the United States, to evaluate their cost-effectiveness and effects on reducing socioeconomic disparities in burden related to RSV, and to monitor the effectiveness and safety of the new interventions.